Host-Microbe Interactions

This application requests support to continue the “Host-Microbe Interactions (HMI) Predoctoral Training
Program” that is the centerpiece of the acclaimed Microbiology and Molecular Pathogenesis Program
(M2P2) at Dartmouth. The HMI Training Program is an interdisciplinary training program that seeks to
provide research and curricular-based training to a pool of talented and highly motivated students who have
been recruited into our trainers’ labs. Particular areas of strength include molecular genetics of bacterial,
fungal, parasitic, and viral pathogenesis, and prion biology, interaction with the innate and adaptive immune
systems, signaling events in host-pathogen interactions, chronic and sustained infections, therapeutic and
vaccine design, and translational research. These areas are pursued using the full range of modern genetic,
molecular, biochemical, immunologic, and computational techniques. The contribution of the HMI Training
Program to the Dartmouth biomedical research community has been overarching and significant as is
reflected in the detailed External Advisory Committee review in 2015. The HMI program consists of 22 well-
funded trainers ($20.8M direct costs in 2017) who currently have 73 trainees in their labs. In 2017, we hired
new faculty whose research is directly aligned with the program goals and who are included as Trainers in
this application highlighting microbiology as an area of investment at Dartmouth. Most importantly, our past
Trainees have been extremely successful with 96% of 32 HMI Training Program Graduates who have left
Dartmouth continuing on in research careers. In total, HMI Trainees have published more than 200 papers
over the twenty-year span of the program. Our program is located within outstanding state-of-the art
facilities with resources housed in modern space in a pleasant working environment. Dartmouth has
invested and continues to invest heavily in its biomedical sciences infrastructure as well as in faculty
recruitment in this area. We request to continue supporting five trainees per year. Students to be trained in
this program are generally selected from the Molecular and Cellular Biology (MCB) multidisciplinary
graduate program, which is the largest graduate program at Dartmouth. Students are nurtured in this highly
interactive environment in which all trainees enroll in a core course, several courses in ethics, and several
advanced courses and career development workshops pertinent to their area of research training. In
addition, they participate in weekly seminar series and journal clubs, and present their work at joint lab
meetings and retreats. The trainees supported by the T32 are provided with a series of additional
enrichment activities, particularly relating to professional development, as described in the Research
Training Program Plan.

Public health relevance
Project Narrative The training program seeks to provide research and curricular-based training to a pool of talented and highly motivated students that have been recruited into our trainers’ laboratories. Students are nurtured in a highly interactive environment in which all trainees enroll in a core course, several courses in ethics, and several advanced courses and career development workshops pertinent to their area of research training. In addition, they participate in weekly seminar series and journal clubs, and present their work at joint lab meetings and retreats, as well as at an annual MCB-wide Research in Progress (RIP) seminar. Our trainees supported specifically by the T32 are also provided with a series of additional enrichment activities, including attending the clinical Infectious Disease Conference, seminar speaker invitations with one-on-one interactions with the speaker, funds for travel to meetings and intensive topic-specific courses, Training Committee supplemental guidance with their Individual Development Plans, and several other activities as discussed in the application. This training prepares our students to go on to successfully pursue a variety of professional career opportunities, many of which will positively impact the health of our citizens and those around the world.